CI Neural Mechanisms

PROJECT SUMMARY/ABSTRACT
Cochlear implants (CIs), which directly stimulate the auditory nerve (AN), are widely considered to be the most
successful neuroprosthetic device. However, patients with CIs do not understand speech as well as people
with normal hearing, and there remains an unmet clinical need to improve performance in established CI users.
CIs are adjusted for each listener by varying the stimulus parameters on each electrode (“programming”);
however, programming techniques have largely remained unchanged since CIs were first approved by the
FDA in 1984. Studies have shown that 1) the estimated density of AN fibers affects speech recognition
outcomes in CI users, 2) AN density can be estimated at each electrode site in CI users, and 3) speech
recognition improves for some CI users when stimulating electrode sites with higher AN density. While these
studies show that speech recognition seems to be at least somewhat dependent on the ability of AN to
precisely code the signal, encoding of information at the level of the auditory cortex is also important for
adequate speech understanding. The present studies will define the role of AN density in the precise coding of
“timing” (temporal) information and quantify the extent to which stimulating electrodes with higher AN density
affects encoding of temporal information at the level of the auditory cortex. We hypothesize that users will
show improved speech understanding when using a CI program that stimulates electrodes with higher AN
density, but these improvements will be associated with more precise encoding of temporal cues within the
auditory cortex.

Public health relevance
PROJECT NARRATIVE Due to expanding cochlear implant (CI) candidacy and awareness, the number of adult CIs performed annually continues to increase. This project is relevant to public health as it examines modifiable factors that can be used to improve speech understanding in CI recipients, which could in turn improve quality of life in hundreds of thousands of individuals with hearing loss. This is relevant to the NIH’s mission as it seeks and applies knowledge to enhance human life.